Bioinformatics, Biostatistics, and Computational Biology Core (BBCC)

BBCC Project Summary
BIOINFORMATICS, BIOSTATISTICS, AND COMPUTATIONAL BIOLOGY CORE (BBCC)
The LBRN Bioinformatics, Biostatistics and Computational Biology Core (BBCC) is an
interdisciplinary core of biostatisticians, modelers, biocomputing scientists, software tool
developers and bioinformaticians with expertise in various biomedical related research areas. In
addition to providing novel and standard statistical methods, this core seeks to support and
collaborate with Investigators in the areas of grant proposal, study design and manuscript and
abstract preparation. This core provides training through seminars, workshops, hands-on
specific training, and direct one-one consultation. BBCC is headquartered and leverages the
computational strengths and manpower of the LSU Center for Computation & Technology
(CCT), which is supported by dedicated funding and reports to the LSU Office of Research &
Economic Development. BBCC provides service following categories. 1) Experimental design
consultation. 2) Computational analysis consultation. 3) Access to high performance computing
systems. 4) Data storage and software installation services. 5) Bioinformatics workshops and
training. BBCC serves to educate, train and support project investigators and their teams across
Louisiana, and to lead and support translational research activities at the frontiers of biomedical
science.
The goals of the BBCC will be accomplished by the following Specific Aims:
Specific Aim I: To maintain and enhance the established LBRN-developed
cyberinfrastructure and provide computational resources expertise and support to all
PUI campuses.
Specific Aim II: To provide bioinformatics, biostatistics, and computational biology,
services and tools to PUI investigators, and leadership and support for translational
biomedical research.
Specific Aim III: To provide organized training and educational support in bioinformatics,
biostatistics, and computational biology to LBRN PUI faculty, staff, and students.

Public health relevance
Project Narrative BIOINFORMATICS, BIOSTATISTICS, AND COMPUTATIONAL BIOLOGY CORE (BBCC) The LBRN Bioinformatics, Biostatistics and Computational Biology Core (BBCC) is an interdisciplinary core of biostatisticians, modelers, biocomputing scientists, software tool developers and bioinformaticians with expertise in various biomedical related research areas. This core provides training through seminars, workshops, hands-on lab specific training, and direct one-one consultation. Headquartered at the LSU Center for Computation & Technology (CCT), BBCC serves to educate, train and support project investigators and their teams across Louisiana, and to lead and support translational research activities at the frontiers of biomedical science.